Advanced Tissue Pathology and Imaging

ABSTRACT
Visualizing and quantifying tissue and cellular pathologies are central to understanding the pathogenesis,
progression, and complications of metabolic disease, and to monitor the effectiveness of its treatment.
Methods of labeling, imaging, and quantifying cellular elements have improved rapidly and are providing new
capabilities to evaluate phenotypes at the sub-cellular, cellular, and whole-organ levels. The Advanced Tissue
Pathology and Imaging Core (ATPI) has been in great demand during the current funding cycle and has
evolved significantly since the last submission to meet the changing needs of DRC investigators.
The ATPI has proven broadly successful in achieving its mission of assisting individual investigators in
histophenotyping. Originally conceived and organized as a histology core and subsequently expanded to
include microscopy, the ATPI continues to evolve to meet the everchanging needs of DRC investigators. It was
successfully reorganized and expanded during the current funding period to include state-of-the-art clearing,
molecular “staining” and imaging technologies. To meet the large and growing demands for these services
identified in investigator surveys and recommended by reviewers in the previous funding cycle, we streamlined
the administrative components of the ATPI by creating an on-line service request system and increased efforts
to provide the heaviest users with the access to equipment and training needed to perform many of the
techniques for themselves. An expert in the implementation of these advanced techniques in both the brain
and peripheral organs, Dr. Lori Zeltser has led the restructuring of the Core. The ATPI services complement
those provided by other DRC Cores, so that investigators who take advantage of DRC resources can fully
characterize the histologic, immunologic, and metabolic function and phenotypes of mice. Thus, the combined
investments by Columbia, the Naomi Berrie Diabetes Center and the DRC have been leveraged to provide
excellent services at low costs.